RESPONSIVITY IN SIBLINGS OF SCHIZOPHRENIC PROBANDS

This research explores the genetic hypothesis of schizophrenia by characterizing first degree relatives of schizophrenic probands by their biological and clinical responses to two drug challenges: apomorphine and MK-212. The GH response to apomorphine and the prolactin, cortisol and hyper-thermic responses to MK-212 are compared to normal controls and unmedicated schizophrenics.